The Dynamics of Human Atrial Fibrillation

Project Summary
Atrial fibrillation (AF) is a major arrhythmia worldwide, causing palpitations, stroke and mortality,
and affecting 2-5 million Americans. Unfortunately, therapy to eliminate AF has had limited success. In
our last funding cycle, we focused on localized drivers as potential AF mechanisms. Mapping of drivers
has now been validated by concurrent optical mapping of human AF, and their features and have been
validated by several other methods in patients. Nevertheless, ablation results for these and other
proposed mechanisms for AF outside the pulmonary veins are mixed. It is unclear if this reflects
difficulties of AF mapping, or different mechanisms between patients.
The project will develop a novel mechanistic framework for AF that simplifies existing indices by
building on scientific consensus that organized AF is easier to treat, and disorganized AF has worse
prognosis. This concept spans many existing indices and may help to reconcile them. We have 3
specific aims: (1) To define if the impact of ablation depends on the extent of organizing surrounding the
ablation site; (2) To establish candidate mechanisms for organized and disorganized AF zones in
individual patients with specific profiles, using machine learning applied to known cases with and without
ablation success in our large registry. This comprises detailed AF maps during ablation and after Maze
surgery, clinical data and outcomes. (3) To use novel clinical tools to predict whether patients will
respond to PVI, other ablation or Maze surgery based on whether targeted regions control larger atrial
areas and their locations.
This study will deliver immediate translational and clinical impact, and directly enable
personalized medicine for AF ablation. We use detailed clinical mapping in patients, signal processing
and computer modeling to develop a novel mechanistic framework and widely applicable clinical tools.
We will use tools including machine learning and statistics to classify mechanisms based upon outcomes
from ablation in individual patients. We will make our data and code available online. Our team is
experienced in electrophysiology, computer science, machine learning, biological physics and statistics.
The proposal is thus highly feasible.

Public health relevance
The Dynamics of Human Atrial Fibrillation Narrative Atrial fibrillation (AF) is an enormous public health problem in the United States, affecting 2-5 million Americans and causing rapid heart beats, stroke, heart failure or death. In this project, the applicant will develop a novel framework to better understand human AF that builds on agreement between several concepts for the disease. The applicant will develop strategies to identify AF patients who will best respond to each of several therapies, to guide personalized therapy.